Development and Plasticity of Neural Circuits Underlying Sound Encoding

Project Summary
Functional diversity of Type I spiral ganglion neurons (SGNs) in the cochlea is a fundamental feature of
mammalian auditory circuits thought to support the wide dynamic range of sound intensity coding. They were
classified recently into three molecularly distinct subtypes (Ia, Ib, Ic). Based on their synapse morphology and
location around the inner hair cell (IHC) circumference, these molecular classes correspond to SGN subgroups
with high, medium and low spontaneous firing rates (SR), respectively, defined previously. Selective loss of Ic
contribution to sound encoding is thought to underlie deterioration of hearing, particularly in noisy conditions,
after acoustic overexposure or due to old age. A thorough understanding of the mechanisms shaping SGN
identities is crucial for re-establishing the afferent response diversity needed for normal hearing. SGN
heterogeneity emerges through at least two major splits in their differentiation trajectory during embryogenesis.
The first one involves maintenance of the transcription factor Runx1 to Ib/Ic precursors and repression in SGNs
that become Ia, while Ib and Ic SGNs segregate further in a subsequent split. Final SGN subtype proportions
are then set postnatally in an activity-dependent manner; in mice lacking glutamatergic transmission from IHCs
to SGNs (Vglut3-/-), most develop as Ia. Runx1 is necessary embryonically and must also be maintained
postnatally to avoid a similar overproduction of Ia SGNs. Here we further characterize the regulatory logic of
SGN diversification in mice using single-cell genomic approaches. In Aim 1, we investigate mechanisms
underlying the first bifurcation of SGN subtype identities featuring downregulation of Runx1 in a subset of
neurons. In Aim 2, we study how heterogeneity in SGN spontaneous activity relates to their transcriptomic
identities and explore whether Ia SGNs can be converted back to Ib/Ic. In Aim 3, we map the gene regulatory
landscape supporting plasticity and stability of SGN identities by performing single-cell multiomic profiling of
SGNs. Together, these studies will advance our understanding of how SGN molecular identities emerge,
remain plastic, and ultimately become stabilized, thereby offering a powerful platform to explore the possibility
of interconversion of SGN identities. These goals are highly relevant for addressing hearing health-related
challenges such as synaptopathy, SGN degeneration, and genetic hearing loss.

Public health relevance
Project Narrative Type I Spiral ganglion neurons (SGNs) process and convey all electrical signal generated in the inner ear to the brain. Of the three known subtypes of SGNs, one is particularly critical for hearing in noisy environments but vulnerable to disconnection and eventual degeneration due to sound overexposure or old age. Here we investigate how the three subtypes of SGNs are generated, focusing on genetic and activity-dependent regulation of their unique identities during development in mice.